Wakaya: Rising Up for Choctaw Youth Health

Empirical data indicate American Indian youth are vulnerable to ill health due to adverse socio-demographic
indices and little physical activity, sedentary behaviors and inadequate nutrition. These factors, which form a
toxic triangle of risk, are compounded by behavioral risks factors such as alcohol, tobacco, and other drug use
(ATOD). If current patterns persist, by 2050 one out of three youth from the Choctaw Nation of Oklahoma, the
third largest AI tribe, will be living with Type 2 diabetes and 70% of the Nation will be obese. Wakaya: Rising
Up for Choctaw Youth Health, is an experiential, outdoor, nature-based program grounded in Choctaw values.
It is a multi-level intervention that integrates components of motivational interviewing, the information-
motivation-behavioral skills model, the Positive Youth Leadership Development framework, and the NIMHD
Multilevel Socio-Ecological Research Framework. With a prospective two-group randomized waitlist-control
trial design among 176 at-risk Choctaw youth (ages 14-18 years), we will assess the culturally grounded
intervention's impact on the primary outcomes of physical activity, sedentary behavior, and healthful food
habits; as well as the secondary outcomes of weight/BMI; and ATOD. Additionally, guided by the NIMHD
Multilevel Socioecological Framework, we will examine the potential mechanisms of change by analyzing how
pathway variables (e.g., nature connectedness) mediate intervention effects. Finally, through Topic Modeling of
qualitative interview data and Ripple Effect Mapping via youth participant and tribal leader focus groups (n=64),
we will explore the community-level impact of Wakaya and create a visual map representing the interconnected
ripple effects of the intervention into the community. The program, supported by promising preliminary data on
this approach among adults and acceptability data from youth, involves a 3-month outdoor intervention (with 4
individual sessions, weekly group sessions, 2 overnight culture immersion camps (7 days total), and a 4-day
Choctaw Trail of Tears walk. Additionally, the intervention builds youth health leadership and community
organizing skills. The research team comprises experts in American Indian health from academe as well as
Choctaw Nation and collaborative efforts among two tribal Departments- Historic Preservation and Behavioral
Health. Findings will be disseminated scientifically as well as shared with the tribe for programmatic
implementation. If efficacious, this intervention will provide evidence for interventions that promote physical
activity and nutrition programs that target green spaces, community gardens, natural/nature trails, and built
environments. The proposed study provides significant and practical information in several areas, including the
feasibility of delivering interventions in nature-based settings across multilevel stakeholders. Should it be
efficacious, the program has potential for widespread adaptation and dissemination to other tribal communities
and could be generalizable to other chronic co-occurring physical activity and food habit-related conditions.

Public health relevance
Narrative Chronic diseases associated with physical inactivity, sedentary behaviors, and poor diet and are the silent killers of the modern era for American Indian communities. Better information is needed on multilevel, outdoor-based, culturally grounded, and sustainable physical activity and healthful diet interventions for Native youth.